Don S. Fredrickson Lipid Research Conference

ABSTRACT
The Don S. Fredrickson Lipid Research Conference (FLRC) brings together scientists and
trainees investigating the impact of lipid and lipoprotein metabolism on the development and
treatment of Cardiometabolic Disease. The FLRC is named after the late Don S. Fredricks who
as the director of the National Heart Institute (now the NHLBI) from 1966 – 1974 and later the
NIH, developed the clinical classification for dyslipidemias (Type I-V), described Tangier's
Disease, and made seminal discoveries in lipoprotein metabolism. Most importantly, he trained
both basic and clinical scientists and practitioners who have had a tremendous impact on the
field of lipoprotein metabolism.
Since 2016 the FLRC has employed a rotating institutional host model and has been hosted by
the University of Kentucky ('16, `17, '21), Vanderbilt University ('18, `23), the University of
Cincinnati ('19), Duke University and the University of North Carolina ('22). The FLRC will be
hosted by the Medical College of Wisconsin in 2024 and return to UK in 2025.
Keynote Lectures at the 2023 Fredrickson conference include Barbara Kahn, Harvard University
and Alan Remaley, National Heart Lung and Blood Institute. The thematic scientific sessions
include: Intestinal Microbiome Control of Lipid Metabolism, Stable Isotope Studies in Lipid
Metabolism, Atherosclerosis Regression and Efferocytosis, Modulators of Triglyceride
Metabolism & Lipoprotein Lipase. The FLRC places a strong emphasis students and fellows,
early career faculty, and underrepresented groups. In accordance with that mission, the agenda
also includes additional scientific sessions dedicated for trainees, a “Poster Pitch” session (5-7,
90-second presentations), and a judged poster session. By design, the agenda affords every
trainee in attendance the opportunity to present their research on stage, network with leaders in
the field, and broaden their scope and understanding of research in lipid metabolism and
Cardiometabolic Diseases.
Our format encourages informal interactions between scientists at all levels, providing an
innovative approach to the exchange of ideas and synthesis that will move the field of lipid
research forward. The conference will have high impact as the program spans basic science
discovery to clinical significance. It is therefore expected that the meeting will provide new
insights not only into basic aspects of lipid metabolism, but also how to treat, and ultimately
cure, a wide variety of Cardiometabolic Disease states.

Public health relevance
Project Narrative The Don S. Fredrickson Lipid Research Conference is an annual meeting held since 1992 that brings together scientists in the field of lipid and lipoprotein metabolism and their impact on cardiovascular and metabolic disease. Its goal is to provide a venue for senior scientists, early career investigators, and trainees to share cutting-edge science; encourage new lines of thinking, experimentation, and collaboration; and the opportunity for host institutions to showcase their research activity to have a greater impact in the advancement of our understanding and treatment of cardiometabolic disease.